Treatment for Alcohol Use Disorder in Medicaid Managed Care

PROJECT SUMMARY
As the nation continues to grapple with rising alcohol-related hospitalization and mortality, expanding access to
alcohol use disorder (AUD) treatment remains an urgent public health priority. While Medicaid is positioned to
be a key policy lever to improve access to AUD treatment and reduce mortality among vulnerable populations,
many state Medicaid programs do not cover the full continuum of AUD treatment and use utilization
management parameters that may restrict access. Moreover, most state Medicaid programs contract with
managed care organizations (MCOs). While over 70% of all Medicaid enrollees participate in MCO plans, little
is known about how these plans cover AUD treatment. To fill this gap in the scientific evidence, we will conduct
the first multi-state study of the effects of Medicaid MCO coverage and utilization management design on AUD
treatment receipt and outcomes. The study will encompass 142 MCO plans, across 18 states, for the full
continuum of treatment. We also propose to make use of innovative random auto-assignment methods in two
state Medicaid programs. Our specific aims will include: (1) estimating how MCO plans’ coverage and
utilization management designs are associated with progression through the major stages of identification and
treatment of AUD (diagnosis, initiation, engagement, and retention); (2) estimating how MCO plans’ coverage
and utilization management parameters are associated with alcohol-related emergency department visits and
hospitalizations; and (3) estimating how progression through the stages of identification and treatment of AUD
is associated with alcohol-related mortality. The proposed study will be the first comprehensive investigation of
the effects of MCO coverage for AUD treatment on treatment receipt and outcomes – evidence without which
the care of a large fraction of the AUD population is compromised. As alcohol-related hospitalization and
mortality continue to rise, evidence regarding the impact of Medicaid MCO coverage for AUD treatment is
urgently needed. This research will equip policymakers with evidence-based guidance on how to structure
MCO contractual arrangements to ensure appropriate and efficient access to AUD treatment.
1

Public health relevance
PUBLIC HEALTH SIGNIFICANCE This study will contribute to public health knowledge of the effects of Medicaid MCO coverage and utilization management design on access to alcohol use disorder treatment, and the effects of Medicaid enrollees’ alcohol use disorder treatment receipt within MCOs on adverse outcomes, namely alcohol-related emergency department visits, hospitalizations, and mortality. The study will provide tangible guidance to states and Medicaid MCO plans regarding how to best structure coverage and utilization management parameters to ensure appropriate and efficient access to alcohol use disorder treatment. 1